Cancer-associated fibroblasts promote thyroid cancer malignancy through Wnt signaling

PROJECT SUMMARY
Many aggressive cancers have a robust tumor microenvironment composed of heterogenous stromal and
immune cells. Although the advent of immune checkpoint inhibitors has shifted therapeutic targets of cancer
research to include tumor-cell extrinsic targets, the therapeutic potential of targeting the tumor stroma remains
underexploited. Recently, cancer-associated fibroblasts (CAFs) have been implicated as drivers of disease
progression. From preliminary attempts to harness the therapeutic potential of targeting CAFs, it has become
clear that targeting CAFs as a bulk population of cells will not be sufficient. As such, there have been efforts in
breast and pancreatic cancer to define the heterogeneity of CAFs. These efforts have yielded diverse subtypes
commonly described by two overarching groups: myofibroblast CAFs (myCAFs) and inflammatory CAFs (iCAFs).
In pancreatic cancer, myCAFs are observed to be tumor-adjacent and iCAFs are more distant from tumor cells.
While defining subtypes of CAFs is a necessary first step, the development of novel therapeutic approaches will
likely require the identification of specific functions of CAF subtypes. To this end, Wnt2 has been identified as
upregulated in CAFs from pancreatic, breast, and colorectal cancer, yet the role of CAF-driven Wnt signaling on
tumor progression remains largely unknown. Anaplastic thyroid carcinoma (ATC) is a lethal disease (~3-5 month
median survival) with an abundant tumor stroma and no efficacious treatment options. The composition of the
tumor stroma in ATC has been largely unexplored. My preliminary work identifies a prominent fibroblast
population in ATC that expresses WNT2. As ATC is known to have upregulated Wnt signaling relative to other
thyroid neoplasms, this provides a unique opportunity to study the dynamics of CAF-driven Wnt signaling. The
goal of this proposal is to define the CAF subtypes present in thyroid carcinoma and determine the functional
role of CAF-derived Wnt2 on tumor growth. I hypothesize that distinct CAF populations promote tumor growth
and invasion in thyroid carcinoma through Wnt signaling and have unique spatial relationships. To test my
hypothesis, I will perform experiments in ATC models and papillary thyroid carcinoma (PTC) models. PTC is a
predominantly indolent thyroid carcinoma that can transform to ATC in vivo, making it ideal for examining the
ability of CAFs to promote disease progression. In aim 1, I will elucidate subtypes of CAFs present in ATC and
PTC and probe Wnt ligand-receptor interactions. Further, I will determine spatial resolution of myCAF and iCAF
fibroblast populations in thyroid carcinoma. In aim 2, I will utilize >40 primary patient thyroid carcinoma CAF
cultures that our lab has collected to demonstrate the role of CAF-derived Wnt2 signaling both paracrine on PTC
and ATC tumor cells and autocrine to shape the phenotype of CAFs. In completing these studies, I will for the
first time define the heterogeneity of CAFs in thyroid carcinoma and characterize a potential novel therapeutic
target applicable to CAFs in multiple cancer types.

Public health relevance
PROJECT NARRATIVE Cancer-associated fibroblasts (CAFs) are a heterogeneous stromal cell population that influence disease course and treatment responses in aggressive cancers. Anaplastic thyroid carcinoma has a substantial stromal component, yet the composition of the stroma and its role in promoting malignancy remain unclear. In this proposal, I will elucidate the subtypes of CAFs in thyroid carcinoma and investigate the tumor-promoting effects of CAF-driven Wnt signaling, providing a novel therapeutic target for a disease with an urgent need for new treatment options.